A COMPREHENSIVE STUDY OF CLINICALLY STAGED PEDIATRIC HODGKIN'S DISEASE

This study will attempt to determine the role of low dose involved field radiotherapy (RT) in pediatric patients with Hodgkin's disease who attain a complete response following initial chemotherapy. Patients will receive 4-6 courses COPP/ABV hybrid chemotherapy and be randomized to receive RT. Stage IV patients receive additional intensive chemotherapy.